Center for the Study of Complex Malaria in India

SUMMARY This Alzheimer's-focused research Administrative Supplements for NIH/NCI Grants that are not focused on Alzheimer's Disease (AD) is requested for the Center for the Study of Complex Malaria in India (CSCMi) 2.0. Recently published data indicate the occurrence of similar pathogenic pathways between cerebral malaria (CM), a severe encephalopathy caused by Plasmodium falciparum, and AD. We will leverage the combination of unique resources afforded by the ongoing Project 3 of the CSCMi 2.0, including a repository of plasma and brain tissue, as well as MRI datasets already acquired from a highly characterized cohort of both adult and pediatric CM patients admitted at Ispat General Hospital in Rourkela, India. In collaboration with AD experts, we will evaluate whether pathogenic events such as axonal injury and microglia dysfunction are involved in both AD and CM, and if so, whether imaging signatures in CM patients can help the early detection of AD using structural MRI. This project will bring together experts from the field of AD and CM to not only generate preliminary data for future multidisciplinary grant applications in and outside India, but also foster cross- pollination across the two research areas to stimulate additional activity leading to progress on AD, in particular new imaging signatures of early onset disease. This supplement is primarily designed as a springboard for future applications aimed at better understanding, diagnosing and, ultimately, treating AD. We will work closely with colleagues at the Clinical Epidemiology Database, ClinEpiDB (http://ClinEpiDB.org), funded by NIAID and the Bill and Melinda Gates Foundation to deposit the data for access by the malaria and AD research communities.

Public health relevance
RELEVANCE The ongoing Project 3 of the CSCMi 2.0 is highly relevant to this call, as our current research is focusing on approaches used in AD research, including magnetic resonance imaging, associated biomarkers and improved diagnosis. Here we propose to evaluate for the first time common pathogenic pathways between CM and AD, an approach supported by recent and ground-breaking publications. Associations between CM and AD have not been evaluated so far, but other infections have been linked to AD and indicate that infections might be causative factors for its inflammatory pathways. In addition to inflammation, our research strongly suggests the involvement of brain hypoxia in CM, a phenomenon that has also been suggested to pay a role in the development of AD. For this supplement, we are planning to further the research agenda of AD by bringing together experts on CM and AD to measure and contrast for the first time axonal and microglia damage processes between the two diseases, and evaluate new tools for the early diagnosis of AD. This approach will to not only allow the generation of preliminary data for future multidisciplinary grant applications in and outside India, but also the fostering of cross-pollination across the two research areas to stimulate additional activity leading to progress on AD, in particular new imaging signatures of early onset disease.